Degrading therapeutically important kinases using small molecules

PROJECT SUMMARY/ABSTRACT
Targeting of oncogenic kinases with small molecule inhibitors is ow a well validated paradigm for treatment of
particular cancer types. Unfortunately, resistance to ATP-competitive inhibitors typically develops due to the
selection for tumor cells that harbor new mutations that induce resistance to kinase inhibitors or due to activation
of by-pass signaling pathways. In addition, many tumors depend on the scaffolding function of a kinase and not
on enzymatic kinase activity, thereby rendering inhibitors ineffective. For example, the pseudokinase HER3 is
an obligate heterodimerization partner with EGFR and HER2 but its kinase activity is not required. In the first
funding cycle, we successfully explored a fundamentally different approach to abrogate kinase signaling by
developing novel small molecules that induce kinase degradation via the ubiquitin-proteasome pathway and
systematically explored the degradable kinome. Here we propose to expand on this extensive fundamental
work to increase coverage of the degradable kinome, further investigate the mechanism of small
molecule-mediated protein degradation and expand probe development to non-degrading molecular
glues. In particular, we will increase the chemical space of potential degraders to not-yet explored kinase ligand
scaffolds as well as recently reported E3 ligase ligands including ligands for ligases such as IAP, MDM2, KEAP1,
DCAF11, DCAF15, DCAF16, AHR, FEM1B, RNF4 and RNF114 and novel ligase attachment geometries for our
previously characterized E3 ligases CRBN and VHL, and will also include the development of trivalent degrader
molecules as a novel compound design approach. We have also developed new and improved global proteomics
workflows to enable increased proteomic profiling of degraders in a panel of up to five different cell lineages,
which will increase identified kinases from ~400 to almost 600 per compound treatment. In addition, we have
developed new chemoproteomics workflows to determine ternary complex formation of glue molecules and are
able to determine ubiquitination sites and profiles of degrader molecules. This extended degrader
characterization data will enable us to further expand our open-source accessible degradable kinome database
and will deepen our understanding of E3 ligase-dependent degradation mechanisms. We will further broaden
our probe development efforts to HER3-targeting non-degrading glue molecules to investigate alternative modes
of action for development of novel therapeutics. The goal of this grant application is to expand the
degradable kinome database by covering an extended chemical space and expanding cellular treatment
conditions, interrogate structural mechanisms of targeted protein degradation and non-degrading
complexes, and assemble a HER3-targeted compound library for the development of non-degrading glue
molecules as a novel therapeutic strategy to modulate HER3 activity in cancer models.

Public health relevance
PROJECT NARRATIVE Kinases have been implicated in almost all cellular processes and are attractive targets in the development of cancer therapeutics, with most drugs depending on kinase inhibition to achieve their therapeutic effect. This grant aims to expand on our previous efforts towards a novel mode of action for protein modulation – Targeted Protein Degradation – which induces complete elimination of the target protein from the cancer cell and thereby not only targets kinase catalytic activity but also important scaffolding functions. To accomplish this, we will develop novel small molecule degrader scaffolds and compound libraries in addition to elevating our compound characterization efforts to increase coverage of the degradable kinome and our understanding of degrading and non-degrading complexes, and we will further introduce the development of non-degrading glue molecules as new drugs for the modulation of (pseudo)kinase activity.